Functional and Structural Diversity in Hypoglossal Motoneurons

PROJECT SUMMARY/ABSTRACT
Tongue muscles, which are innervated by hypoglossal motoneurons (XIIMNs), are critical for survival given their
role in suckling, swallowing, mastication, breathing and more advanced functions such as human speech. The
hypoglossal motor nucleus is a bilateral collection of seven separate motoneuron pools, with motoneurons in
each pool innervating one of the seven different tongue muscles. We recently showed that XIIMNs innervating
the superior longitudinalis and genioglossus tongue muscles of neonatal rats have significantly different resting
membrane potentials, action potential firing thresholds, and f-I curves, i.e., the change in firing rate as a function
of injected current. These findings raise three very important questions: 1) what is the extent and nature of
phenotypic diversity both within and between individual XIIMN pools? 2) what are the anatomic and ionic
mechanisms that underlie this phenotypic diversity? 3) do structural and functional differences among XIIMNs in
each pool map to unique gene expression profiles? We propose a rational and robust approach to address these
questions: specifically, to describe the morphology, intrinsic membrane properties, and the transcriptome of
muscle specific XIIMNs. Our initial targets are XIIMNs innervating the genioglossus, hyoglossus and superior
longitudinalis muscles, as each muscle has different effects on tongue movement. Muscle-specific XIIMNs will
be identified by injecting each of the muscles with a retrograde tracer conjugated to a fluorescent reporter. All
experiments use brain tissue from neonatal rats 5-12 days of age. Key techniques include neuroanatomic tracing
to define neuron morphology, immunohistochemistry, whole cell patch clamp electrophysiology and next-
generation RNA sequencing. These basic science studies will identify unique molecular targets associated with
functional and/or structural differences between the motoneuron pools. Without this fundamental information,
interventions aimed at stimulating or inhibiting the activity of specific tongue muscles will be imprecise and may
result in unintended outcomes. In contrast, specific knowledge of unique molecular targets will focus the
development of therapeutic approaches aimed at stimulation and/or inhibition of specific tongue muscles.
Preliminary data show several pool-specific differences in motoneuron function and gene expression, strongly
suggesting that the proposed work will provide truly novel data on the anatomic, physiologic, and molecular
underpinnings of phenotypic diversity within and between muscle-specific hypoglossal motoneuron pools. This,
in turn, will lead to a major leap in our understanding of how the tongue muscles perform complex, coordinated
behaviors such as suckling, swallowing, and defense of the upper airway during sleep, and will lay the foundation
for the development of therapies aimed at controlling the activity of specific tongue muscles.

Public health relevance
PROJECT NARRATIVE Beginning at birth, the activity of eight different tongue muscles must be precisely coordinated for the successful performance of diverse tasks such as breathing, suckling, and swallowing but how this is accomplished is unknown. Tongue muscles are innervated by motor neurons in the hypoglossal motor nucleus of the brainstem, which is a bilateral collection of seven motor neuron pools, with motor neurons in each pool innervating a different tongue muscle. The proposed basic science studies will reveal unique physiologic and genetic properties of the motoneurons that supply a given muscle, which can then be targeted to activate or inhibit specific tongue muscles.